Traffic Intersection Analysis Algorithms for the Blind

DESCRIPTION (provided by applicant): This project aims to explore, develop and test computer vision algorithms to analyze images of street intersections from a camera worn by a blind person. Urban intersections are the most dangerous parts of a blind person's travel. They are becoming increasingly complex, making safe crossing using conventional blind orientation and mobility techniques ever more difficult. We will explore computer vision algorithms to help a blind person find the crosswalk, find the pedestrian signal button, determine when the "walk" light is on, and alert him/her to any veering out of the crosswalk. We will emphasize the development of completely novel methods of analyzing non-ideal images including shadows, occlusions and other irregularities using spatial grouping techniques based on Bayesian inference. The resulting algorithms are intended for eventual integration as modules for a computer vision system we are already developing to help blind persons with travel tasks such as finding and reading aloud printed signs and negotiating street crossings. The combined system would have potential for a radical advance in independent travel for blind persons. In this exploratory project, we aim to: (1) Explore and test alternative approaches to algorithm design to process intersection images and extract the information about the crosswalk, crossing signal, etc., using a database of real-world images taken by blind persons at a variety of different kinds of intersections. (2) Test the algorithms using a portable camera connected to a notebook computer with speech output.